Roybal Center for Dementia Family Caregiver Mastery

The goal of the Emory Roybal Center for Dementia Caregiving Mastery is to provide support to investigators
across the nation to conduct NIH Stage I-III behavioral intervention research that will enhance the context-
specific role-mastery of informal caregivers of persons living with Alzheimer’s disease and similar illnesses. By
2050, as many as 20 million Americans will be living with these illnesses, and the number of informal
caregivers will expand to 40-50 million. Informal caregiving is the key to the quality of life and continued
community living of persons living with Alzheimer’s and similar illnesses; it is also a bulwark against rising
health care costs. Our Center rests on the premise that informal caregiving is not one homogenous entity but is
context-specific. As the U.S. continues to experience major reconfigurations in its social and demographic
composition (we will, for instance, be a “minority majority” country by 2043), we expect caregiving to occur in
an ever-increasing set of heterogeneous contexts. These contexts are framed by various illness conditions,
family, cultural, or social caregiving situations, geographical location, and care recipients’ transitions through
care settings, especially the acute setting. The two clinical trials proposed in this application exemplify such
heterogeneous contexts: one focuses on the culturally-grounded challenges faced by Latino caregivers; the
other on the situation of individuals who, newly discovering they are in the caregiving role, need immediate
orientation to the role. Our Center’s second assertion is that interventions developed to address these contexts
must be designed with the involvement of caregivers/consumers from within these contexts (as have the two
proposed trials). Our Center builds on the successes of our first cycle of nationally competed projects (13
supported projects, most from national investigators), the majority of which have or are poised to receive
support for advancement to the next stage of development and testing. The Center is anchored in a set of
existing collaborations with other AD Roybal Centers and key national networks of Alzheimer’s and caregiver
researchers (e.g., the IMPACT Collaboratory) and investigators engaged in geriatrics and gerontology
research. Through webinars and a national Caregiver Research Interest Group, our Center will continue to
engage investigators and consumers in discussions about and design of interventions. Acting as a kind of
“academic venture capital enterprise,” we will employ established structures and processes to attract
competitive trial applications, guide investigators in the development of effective trial proposals, apply rigorous
methods for selecting meritorious proposals, and, through our Behavioral Intervention Development Core,
mentor and monitor supported trials to ensure intervention trial success. Through our Consult Service, we will
work with supported investigators to produce tangible returns on our “investments:” successful proposals for
the next stage of intervention development and testing. The inter-related activities of the Center will enable it
to pursue a second overall aim, the continued advancement of the science of intervention development.

Public health relevance
Public Health Relevance. The proposed Center addresses the need to strengthen the capacity of informal caregivers of persons living with Alzheimer’s and similar illnesses to provide guidance and care to those individuals and, therefore, enable them to live in the community and not in institutional settings for as long as possible. Addressing the need to promote caregiving mastery in heterogeneous caregiving contexts is central to the quality of life of those living with these illnesses and may contribute to restraining the growth in health care expenditure associated with them. The Center will support the design, development, implementation, and stage-advancement of mechanism-based behavioral intervention clinical trials, especially stage I and II trials, proposed by researchers across the country and aimed at specific caregiving contexts.